2017 National Conference on Interstate Milk Shipments

2017 NCIMS Project Summary The National Conference on Interstate Milk Shipments (NCIMS) is a non-profit educational organization composed of state, local and federal regulatory officials responsible for milk sanitation rating and enforcement of Grade A milk sanitation laws, dairy industry personnel, academic researchers and advisors and consumers. The Conference meets biennially in odd-numbered years, the next meeting being May 12-17, 2017 at the Amway Grand Hotel in Grand Rapids, Michigan. The primary business of the Conference is to deliberate proposals submitted by individuals from various regulatory agencies and from the dairy industry, who have an interest in ensuring that the dairy products available for sale and consumed throughout the United States are safe. The mission of the NCIMS is “To Assure the Safest Possible Milk Supply for All the People.” An Executive Board comprised of twenty-six (26) individuals from state and local milk regulatory agencies and dairy-related industries, one representative from the United States Public Health Service (USPHS) Food and Drug Administration, one representative from the Unites States Department of Agriculture. one representative representing consumers, one representative representing Third- Party Certifiers, the Laboratory Committee Chair and the Program Committee Chair, govern the Conference. At the Conference, delegates from each of the fifty states and one United States Trust Territory that participate in the Interstate Milk Shippers program send a delegate to make final decisions on the various proposals that are submitted. These decisions impact all regulations pertaining to interstate shipments of milk and milk products; impact the milk regulatory programs in each of the states and ultimately impact the safety of milk and milk products produced and distributed under these regulatory requirements. Therefore, it is very important that all states be represented. Due to financial constraints, some states have not been able to send a voting delegate to the Conference in previous years. The grant will allow NCIMS to assist those states in sending a delegate to the 2017 Conference. Funds from the grant will be used to pay travel expenses, lodging, and per diem, for the 2017 Conference for some states who apply and otherwise might not be able to attend and participate in the conference.

Public health relevance
2017 NCIMS Project Narrative The National Conference on Interstate Milk Shipments (NCIMS) is requesting funding for delegate travel to its biennial meeting on May 12-17, 2017 at the Amway Grand Hotel in Grand Rapids, Michigan. The NCIMS was established to ensure the safety of the milk supply in the United States and to provide for uniform regulation and enforcement of milk regulations across the United States. It is critical to the on-going success of the Grade A Milk Program that all of the state/trust territory agencies that conduct milk regulatory and sanitation rating programs are able to participate in and learn from the presentation of public health and safety information and to effectively deliberate the proposals that are made to improve the documents which govern the conference and which are ultimately provided to the states as the basis for their respective Grade “A” programs.